Investigation of the role(s) chlamydial polymorphic membrane proteins (Pmps) play during infection with C. trachomatis

Abstract
Chlamydia trachomatis is an obligate intracellular, Gram-negative human pathogen causing a
variety of acute as well as chronic diseases. This bacterium infects primarily epithelial cells of
mucosal surfaces of the urogenital tract and the human eye. Chlamydia-mediated genital
infections represent the leading cause of bacterial STDs in the United States, with 1,649,716
infections reported to the CDC in 2022. Conversely, Chlamydia-mediated ocular infections
cause follicular conjunctivitis, which can result in scaring of the eyelid and blindness. C.
trachomatis is subdivided into 15 major serovariants based on antibody response of infected
patients to the chlamydial porin, major outer membrane protein (MOMP). In addition to MOMP,
sera obtained from chlamydia-infected individuals showed a significant reactivity to the surface
exposed autotransporters, polymorphic membrane proteins (Pmps). Although all nine, pmpA to
pmpI of C. trachomatis are immunogenic, PmpB, C, D, and I are the most prevalent. This family
of proteins are chlamydial adhesins secreted by type V secretion system and represent potential
virulence factors, yet their role during chlamydial pathogenesis is mostly still unknown. Our
preliminary data indicate that pmpI may play a distinct role(s) in infectious elementary bodies
than in replicating reticulate bodies. We show that the deletion of pmpI in C. trachomatis
resulted in an impaired initial infection with chlamydial elementary bodies, but a formation of
smaller chlamydial inclusions and a reduced number of new infectious progeny was also
observed. We propose to delineate the specific function(s) of pmpI during different stages of the
chlamydial developmental cycle. Since Pmps are predicted chlamydial adhesins, we also intend
to identify and characterize either eukaryotic and/or chlamydial pmpI interacting partner(s)
during infection with the microorganism. Furthermore, we propose to utilize the conditionally
replicating pKW shuttle vector in targeting the entire Pmp loci in order to determine whether
individual Pmps of each locus may assume similar or distinct function during attachment,
invasion, and/or throughout the developmental cycle. Phenotypical analyses of ∆pmpABC,
∆pmpFE, and ∆pmpGH chlamydiae will be compared with WT and corresponding cis-
complemented strains. Phenotypical outcomes will also be tested with other chlamydial species
and various human and murine cell cultures to identify possible species-specific and host-
specific interactions.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Surface-exposed proteins of infectious organisms represent major mediators in interactions between pathogens and their host. We propose to identify and characterize interacting partner(s) of Chlamydia polymorphic membrane protein, pmpI and determine the role this Pmp is playing in pathogenesis of chlamydial infection. To further understand the significance of Pmps in diseases with these bacteria, we intend to investigate the pmpABC, pmpFE, and pmpGH loci.